Development and Pilot Study of Primary Care Loneliness Interventions to Prevent Suicide

Project Summary/Abstract
Suicide is a leading cause of death in the US with an estimated 46,000 suicide deaths occuring in 2020.
Loneliness, an interpersonal risk factor for suicide, was recognized as having reached epidemic proportions by
the US Surgeon General in 2017 before rates further worsened due to the COVID-19 pandemic. Given the
public health impact of loneliness, the National Academies of Engineering, Sciences, and Medicine have called
for health systems to take an active role and intervene to reduce loneliness. Primary care is the optimal health
system setting to deliver loneliness interventions to prevent suicide because primary care increasingly screens
for loneliness along with other social determinants of health. Primary care practices also increasingly employ
behavioral health care managers who can deliver loneliness interventions along with treatments for depression
and anxiety disorders that may impair recovery from chronic loneliness and contribute to suicide risk. Prior
primary care approaches to loneliness have had mixed results and there remains no established, effective,
ready-to-adopt model to reduce loneliness and suicidal ideation in primary care.
This study will adapt two loneliness interventions, social prescribing and brief cognitive therapy, to be delivered
within primary care. Social prescribing addresses the structural determinants of loneliness (i.e., breadth and
frequency of social interactions) by linking patients to community-based organizations or activities (e.g.,
volunteering) whereas brief cognitive therapy addresses the cognitive determinants of loneliness (i.e.,
relationship expectations) through education, reflections, and guided exercises. In contrast to prior studies,
both interventions will be adapted to be delivered by a behavioral health care manager working within a
primary care-based collaborative care management program. The specific aims of the project are: 1) Adapt
social prescribing and brief cognitive therapy interventions for loneliness to be delivered as components of
primary care collaborative care management and 2) conduct a randomized controlled pilot study (N=60) to
determine feasibility and acceptability of the two interventions and trial protocols.
The Aim 1 development activities will be guided by the ADAPT-ITT (assessment, decision, administration,
production, topical experts, integration, training, testing) framework and will engage patient and provider
stakeholders to inform production of manuals to guide training and pilot testing of the interventions. In the Aim
2 pilot study, patients from two primary care sites who screen positive for loneliness and suicidal ideation will
be randomly assigned to one of the two interventions or to EUC. At 3 months, participants in the intervention
arms will receive the alternate intervention for an additional 3 months, and EUC participants will continue to
receive EUC. Feasibility and acceptability will be measured to inform a future adequately powered trial to
determine the interventions’ mechanisms and effectiveness for reducing loneliness and suicidal ideation.

Public health relevance
Project Narrative Suicide is a leading cause of mortality, and suicide deaths have increased substantially in the US over the past two decades. Loneliness is a prevalent risk factor for suicide that has worsened following the COVID-19 pandemic, yet there is a paucity of effective primary care interventions to address loneliness. This study will develop and pilot test two primary care interventions, each utilizing complementary mechanisms, to improve loneliness and reduce suicidal ideation within a model of collaborative care to enhance intervention effectiveness and implementation.